Patient-Centered Assessment of PTSD

Background: Health literate healthcare organizations integrate health literacy considerations into all
processes of care, including assessment materials. Attention to health literacy is also central to the clear
communication and informed choice that guide trauma-informed care. Posttraumatic stress disorder (PTSD) is
the hallmark mental health condition of Veterans Health Administration (VHA), affecting 23% of all users.
Over one-third of Veterans with PTSD report health literacy-related difficulties understanding written
materials and navigating care. The PTSD Checklist for DSM-5 (PCL-5) poses a substantial response burden,
due to literacy level and length, which has been shown to impact the precision of scores. Disadvantaged
populations of Veterans will be most affected, as they are at increased risk for both exposure to trauma and
limited health literacy.
Significance: [Effective and equitable care will rest on our ability to identify health literacy challenges and to
reduce the literacy demands of patient-reported PTSD assessment. Doing so will help bring PTSD assessment
in line with modern psychometric standards and federal recommendations for drug development and
performance measurement. Prior efforts to minimize burden of PTSD assessment have focused on statistical
approaches to reduce the number of items administered. Few studies have focused on core elements of content
validity by addressing comprehension or health literacy and none benefitted from the substantial expertise in
traumatic stress measurement possessed by the study team.] These goals are consistent with VHA research
priorities for PTSD, broader Department of Veterans Affairs strategic priorities for tailored care and services to
promote equity and access, ethical considerations for clinical research and Healthy People 2030 goals.
Innovation & Impact: We blend the modern psychometric methods of the Patient-Reported Outcomes
Measures Information System with Veteran engagement to achieve study aims. This approach yields data that
supports the comprehension and acceptability of the measure for relevant patient populations. [A low-literacy
PTSD measure would significantly reduce response burden and enhance efficiencies for a broad range of
clinical processes, such as screening, assessment, and measurement-based care.] Work to fill the gap in PTSD
assessment measures must take advantage of the expertise in VHA and must address the needs of Veterans.
Specific Aims: [The proposed pilot will: a) test common screens for health literacy and adapt, augment or
substitute with items tested in prior work to improve comprehension, relevance and acceptability; b) test PCL-
5 items to document comprehension and acceptability among Veterans; c) refine, revise, and retest PTSD
symptom items to achieve Veteran comprehension and acceptability while maintaining content validity; and d)
explore the utility of health literacy screens to detect comprehension difficulties for PTSD items. We will test
newly developed items with a preliminary item analysis using data from a brief web-based survey.]
Methodology: We will use purposive sample to ensure variability in symptom severity, gender, and trauma
type. Cognitive interviews are the gold-standard for assessing comprehension and acceptability among a
measure’s target population. Data will be coded using rapid qualitative analysis. Expert item review will be
used to monitor content validity.
Next Steps/Implementation: [Results will provide valuable information to program partners about
Veteran comprehension and acceptability for the PCL-5 and health literacy screens. If difficulties are found for
health literacy items, we will substitute with additional items cognitively tested in prior work. If comprehension
difficulties are found for PTSD items, we will produce a candidate item pool of low-literacy PTSD items. This
will establish the potential for a subsequent IIR for psychometric validation of these items to produce a low-
literacy low-burden patient-reported measure for PTSD.]

Public health relevance
Posttraumatic stress disorder (PTSD) is common among Veterans who use Veterans Administration (VA) healthcare. Patient-reported outcome measures (PROMs) used to assess PTSD can be lengthy and complex. Research shows that some individuals have difficulty understanding these measures, which increase the response burden. Burden will be greater among those with limited health literacy, or difficulty accessing, understanding, and applying health information. This pilot study will reveal if a low-burden, low-literacy PTSD PROM is needed. We will also find screens for health literacy to help identify Veterans who would benefit from this measure. An easy-to-understand PTSD PROM would make processes of care easier for Veterans and Providers across screening, assessment, and measurement-based care. The proposed pilot aligns with VA priorities and benefits from the strong measurement expertise and prior work of the investigators and a Veteran-engaged research plan.